SenNet Supplement CODCC

SenNet CODCC Supplement Abstract
The purpose of the Supplement is to further the CODCC Administrative Core (Sub-Section C:
Administrative Core: Including Consortium Coordination & Outreach) in three areas: 1.
onboarding each of ten additional murine awards and integrating them into consortium,
2. developing and executing a comprehensive, nationwide, underrepresented scientific
internship award program in cellular senescence based on the NIH criteria, and
3. expanding opportunities to gather, in person, the consortium and others focused on related
technologies and platforms.
Given the large expanding of consortium awards focused on murine data, additional support
and coordination will be required to handle the rapid growth in the development of the broader
overall SenNet eco-system. This includes coordination with other single cell platforms at a larger
scale to best serve the expanded SenNet Consortium adding substantive murine focus, and the
broader research community.
Internships will allow learning valuable new skills across the scientific research spectrum and
gain experience in an educational lab environment. During the internship program, students will
conduct cutting-edge research, greatly expanding their knowledge of biology and data analysis.
Students will develop a variety of skills throughout the summer.
CODCC received significant input in year one in working groups and from NIH regarding the
consortium’s interest in meeting in-person more often, and particularly in focused areas among
awards and outside parties with shared interest. These interests cover both biology laboratory
technologies and associated computational pipelines. Following through on this will require
additional management of meetings, workshop/panels/working groups, & data-thons and
hackathons. To achieve these aims will also require expansion of communication and
engagement to other common fund consortia, among the vendor ecosystem, and to the public
interested in the science of Cellular Senescence and its human impact.

Public health relevance
SenNet CODCC Supplement Project Narrative The purpose of the Supplement is to further the CODCC Administrative Core in three areas: 1. onboarding and integrating new additional murine awards; 2. developing and executing an underrepresented scientific internship; 3. expanding in person consortium activities.